Protein Transport Across Membranes

PROJECT SUMMARY
The goal of this project is to understand in mechanistic terms how proteins are transported across
membranes. One aspect of this proposal is to clarify how misfolded endoplasmic reticulum (ER) proteins are
retro-translocated from the ER into the cytosol (ER-associated protein degradation, ERAD). The proposal is
based on recently determined cryo-electron microscopy (cryoEM) structures of the Hrd1 complex that elucidated
how luminal proteins are retro-translocated, and on experiments that clarified how the Cdc48 ATPase processes
its substrates. Another aspect of the proposal deals with protein import into peroxisomes. Our recent results
indicate that folded cargo translocates with its receptor into the lumen of peroxisomes; the receptor subsequently
returns to the cytosol through a retro-translocon formed by a heterotrimeric ubiquitin ligase complex. Here, we will
address central outstanding questions of these protein translocation pathways:
Specific aim #1: How are proteins moved from the ER lumen across the membrane?
We will clarify the mechanism by which misfolded glycoproteins are delivered to the Hrd1 complex and moved
through the membrane.
Specific aim #2: How are substrates moved from the ER membrane to the proteasome?
We propose to determine how the Cdc48 complex moves substrates into the cytosol and test the hypothesis that
membrane proteins are extracted together with bound lipids. We will investigate how shuttling factors and Cdc48-
binding cofactors transfer substrates between Cdc48 and the 26S proteasome.
Specific aim #3: How are proteins imported into peroxisomes?
Based on preliminary experiments, we propose to test the hypothesis that Pex13 forms a nuclear pore-like
structure through which cargo-bound receptors move across the peroxisomal membrane.
Specific aim #4: How are receptors recycled back into the cytosol?
We will test our model that the ubiquitin ligase complex forms a retro-translocation channel for recycling
receptors. We will use purified proteins to reconstitute ubiquitination by the ligase complex and the subsequent
membrane extraction by the Pex1/Pex6 ATPase.
The mechanism of ERAD and of peroxisomal protein import are of great medical importance. Many diseases,
including cystic fibrosis, are caused by the misfolding of ER proteins and their degradation. The pathway is also
hijacked by certain viruses and toxins, and a better understanding may lead to new drugs allowing interference.
Our work may also lead to a better understanding and treatment of peroxisomal disorders, such as Zellweger
syndrome.

Public health relevance
Project Narrative The translocation of proteins across membranes is a fundamental process involved in the biosynthesis and degradation of a large class of proteins. The medical importance of translocation is demonstrated by the large number of diseases, including cystic fibrosis and α1-antitrypsin deficiency, which result from the misfolding of ER proteins and their subsequent degradation in the cytosol, as well as by peroxisomal disorders, such as Zellweger syndrome. A better understanding of the translocation processes may elucidate the causes of these diseases and result in the development of drugs that allow selective interference.